Understanding and using gene-by-context interactions in human complex trait genetics

Understanding the genetic architecture of complex traits is critical for personalized medicine, as knowledge of underlying risk loci is required for treatment and prediction of disease state. Genome wide association studies (GWAS) have identified hundreds of thousands of genotype-phenotype associations. This information – incorporated in Polygenic Risk Scores (PRS) – has provided levels of prediction accuracy for some complex diseases and health-related traits comparable to those obtained for monogenic diseases. While this is an important advance, significant problems still need to be overcome to achieve the ultimate goal of precision medicine. First, prediction accuracy is low for most complex traits. Possible reasons for this observation are the higher polygenicity of these traits, requiring larger sample sizes to discover associated loci and estimate their effect; and gene-by-context interactions that are usually ignored in prediction models. Second, results obtained in a population usually transfer poorly to a different population and are therefore not generalizable. This is due to differences in effect sizes across populations because of different patterns of linkage disequilibrium (LD) and allele frequencies and/or gene-by-context interactions. My research program will focus on investigating the role of gene-by-context interactions on the genetic architecture and polygenic prediction of complex traits. My first goal is to elucidate the importance of gene-by-context interactions for complex traits. To do so, I will develop a new analytical strategy using a combination of methods that will increase the power for discoveries. This will result in a comprehensive assessment of the contribution of gene-by-context interactions to complex trait variation. My second goal is to evaluate the utility of accounting for gene-by-context interactions to improve phenotypic prediction. To do so, I will use statistical methods developed for agricultural breeding that have been successful at increasing complex trait prediction accuracy in that field. I will also develop a prediction method that models gene-by-context interactions explicitly, while simultaneously accounting for other sources of effect heterogeneity. The long-term goal of my laboratory is to increase prediction accuracy for medically relevant traits in the general population.

Public health relevance
Genetic discoveries made in a population usually transfer poorly to a different population and are therefore not generalizable. The goal of the proposed research program is to improve the accuracy and generalizability of phenotypic prediction by quantifying the importance of and accounting for interactions between genes and external contexts such as environmental conditions. This research will provide a novel analytical strategy/methodology that can be applied to any trait of interest and will be a significant advance towards effective personalized medicine.